Cumulative Lead Exposure in Veterans with PTSD: Examining Firearm Use and Cognitive Therapy Outcomes with novel portable X-Ray Fluorescence

PROJECT SUMMARY
Veterans are at significantly high risk for post-traumatic stress disorder (PTSD), depression, and suicide by
firearm; all three are linked to lead exposure. Preliminary evidence from our team identified firearms as a
significant source of lead exposure in civilians, likely through take-home dust from lead-based primers and
ammunition. Disconcertingly, the mental and physical impact of lead exposure remains poorly understood due
to a focus on acute (blood) rather than cumulative (bone) measures and despite the passage of the 2022
PACT Act encouraging research on Veterans Exposures. When considering cases of PTSD, depression, and
suicidal ideation, one of the most successful treatments is Cognitive Processing Therapy. Cognitive Processing
Therapy is rooted in cognitive behavioral theory; as such, individuals with diminished cognitive abilities and
heightened anger experience worse treatment outcomes. Thus, the well-established effects of lead on lower
cognitive abilities and elevated hostility may limit the efficacy of Cognitive Processing Therapy. To address the
gaps in the literature and enhance the health of Veterans and active duty servicemembers, there is a vital need
to: 1) understand how specific sources of lead exposure (e.g., firearm use) impacts overall lead levels within
this vulnerable population; and 2) understand the impact cumulative lead exposure has on Cognitive
Processing Therapy outcomes. To fill these critical gaps, we plan to leverage an ongoing study of 350
Veterans and active military servicemembers who provided comprehensive self-report measures of
psychopathology, clinician interviews, firearm and lead exposure, and novel noninvasive in vivo 3-minute bone
scans for cumulative lead exposure via portable x-ray fluorescence (pXRF). Next, we will examine the
association of all-cause tibia lead levels with clinical outcomes (pre-and post-treatment, 3-,6-, and 12-months
after treatment). This study will be the first to characterize firearm-related sources of cumulative lead exposure
and all-cause leads effect on psychosocial treatment outcomes in Veterans and active duty servicemembers.
The findings could improve mental health outcomes through actionable insights for participants and providers,
eventually informing and enhancing psychosocial treatment options, of which there are none for adult lead
exposure. This Ruth L. Kirschstein National Research Service Award (NRSA) Individual Predoctoral Fellowship
(Parent F1) application aligns with my goals of becoming an independent and interdisciplinary researcher
through the provision of valuable mentoring, protected research time, and coursework outside my graduate
programming.

Public health relevance
PROJECT NARRATIVE This research will bridge a critical gap in understanding the extent to which firearm-related lead exposure contributes to the total body burden of lead in Veterans and active-duty servicemembers and, within Veterans who are at great risk of all-cause lead exposure, whether the documented effects of lead on the brain significantly impact their response to Cognitive Processing Therapy treatment for PTSD, depression, and suicidal ideation. By identifying key factors related to lead exposure and its impact on therapy efficacy, this study will enhance our knowledge of environmental influences on mental health and contribute to improved treatment protocols, ultimately promoting better health and reducing illness among Veterans.